Nuclear and chromatin mechanics in cell fate specification

We have made significant progress in all 3 research areas of interest this year, especially as it pertains to setting up the tools and pipelines with which to interrogate key open questions of interest to the lab and fields of nuclear and chromatin mechanics and cell fate specification. Specifically we optimized LADome proteomics approaches in a human cell line and designed strategies to transition the system to hiPSC system. In a collaborative effort with NCIFrederick MHL unit we performed an imaging screen on a panel of colorectal cancer TMA samples accessing nuclear shape, chromatin state, mechanontrunsduction, and stemness at single cell-level resolution and redesigned pipelines for all image analyses studies which are currently ongoing. In addition we set up all the necessary in vitro cellular systems (2-and 3-dimensaional colon/colorectal cancer cultures with modulated wnt signaling) and tools (antisense oligonucleotide- and si-RNA-mediated silencing, etc) with which to validate our imaging screen.